Cancer Research Training and Education Coordination

CANCER RESEARCH TRAINING AND EDUCATION COORDINATION (CRTEC)
PROJECT SUMMARY/ABSTRACT
CRTEC leverages Rutgers Cancer Institute’s multi-disciplinary environment, resources, and
Consortium to train a comprehensive workforce of Basic, Clinical, and Population Researchers in
partnership with the Office of Community Outreach and Engagement (COE). An Internal Advisory
Committee (with representation from Research Programs, COE, and other stakeholders) and an
External Advisor provides additional guidance. CRTEC supports curriculum development and
submission of individual and institutional training grants, and coordinates incentives for trainees
who receive external grant funding and travel awards to present at regional/national meetings.
CRTEC initiatives are integrated with Research Programs across the Consortium. CRTEC
collects vital trainee metrics to report to key stakeholders and for grant submissions. Aligned with
the cancer institute’s Strategic Plan, CRTEC aims to: 1) leverage strengths of the Consortium to
secure Training Grants to develop the next generation of Basic, Clinical, and Population
Researchers; 2) organize educational initiatives that integrate with Research Programs to
contribute to training across the Consortium and the community; 3) provide mentorship and
comprehensive University-wide resources to trainees and junior faculty to support professional
development; and 4) establish programs for trainees who face challenges in educational access
and achievement to advance research and reduce negative cancer health outcomes in our
catchment area. Eleven NIH institutional training grants (4 from NCI) were secured by CCSG
Members in this grant period, with two other NIH training grants at Princeton University (PU)
involving Members as mentors; Members/their trainees also secured 17 NIH individual training
awards (5 F, 7 K, 5 R00). NCI-funded institutional training grants increased from zero to four and
individual NIH training grants increased from 23 to 27 (17%) compared to the last funding period.
Rutgers Cancer Institute faculty secured new NCI funding to train high school science teachers
and students (high school, undergraduate, medical) from access-challenged backgrounds (R25
and Supplement); secured an NCI T32 Training Grant for post-doctoral trainees; developed new
undergraduate summer internship programs with PU and undergraduate and graduate programs
with regional academic institutions including Middlesex College; mentored >500 research and
>50 clinical trainees; and reached thousands of K-12 students through the Rutgers Youth Enjoy
Science Program and other initiatives. Future plans include securing additional training grant
funding with research mentors from across the Consortium, developing Consortium-wide training
initiatives, and collaborating with COE to engage the communities in our catchment area.

Public health relevance
PROJECT NARRATIVE Not required per PAR-21-321 (Cancer Center Support Grants (CCSGs) for NCI-designated Cancer Centers (P30 Clinical Trial Optional)